Glucose patterns and cardiac arrhythmias in older adults with diabetes

Abstract
Type 2 diabetes and cardiac arrhythmias are both highly prevalent in older age. There is growing awareness
that diabetes affects the electrical conduction system in the heart. Asymptomatic arrhythmias are thought to be
particularly common in older adults, especially in the setting of diabetes. Many of these arrhythmias are
thought to be harmful, but their impact on cardiovascular outcomes and mortality in older adults with diabetes
is not clear. Prior research has shown that glycemic variability and hypoglycemia in diabetes contribute to a
high burden of atrial and ventricular arrhythmias. However, prior studies have not collected concomitant
information on glucose patterns and ECG recordings. We contend the glycemic patterns (low, high, and
variable glucose) may acutely contribute to cardiac arrhythmias in diabetes. To address this question, we will
conduct continuous glucose monitoring and leadless “patch” ECG monitoring in a population of adults with
diabetes aged 60 years and older to assess coinciding variations in glycemia and cardiac rhythm. We will
relate these patterns to current health status and long-term clinical outcomes. Our research will inform the role
of low, high, and variable glucose in leading to cardiac arrhythmias and subsequent outcomes in older adults
with diabetes.

Public health relevance
Narrative Cardiac arrhythmias are common in older age and strongly linked to diabetes. State-of-the art leadless “patch” ECG and continuous glucose monitoring technology provide novel means to evaluate the link between disordered glucose patterns and the occurrence of cardiac arrhythmias in adults with type 2 diabetes. The proposed project will provide evidence-based guidance regarding how low, high, and variable glucose may contribute to the occurrence of cardiac arrhythmias and subsequent health outcomes in the setting of diabetes.